Field-Deployable, low-Cost Point-of-Need urine test strips for mobile quantification of SUD medication drugs and their metabolites

Project Summary
Substance Use Disorders (SUD) has become a major public health crisis of our times. Although
medications for SUD have been available, many patients often encounter significant barriers to
receiving a diagnosis and treatment for SUD because there are no devices for rapid and low-cost
quantitative measurement of drug concentrations and their metabolites that can be used for monitoring
the compliance and metabolism of SUD medication drugs (buprenorphine, Methadone, Naltrexone) in
patients who are undergoing opioid dependence therapy or pain management in low-resource setting
or at home. We propose to develop a low-cost, disposable, point-of-use, highly sensitive and specific
non-instrument urine test strip that enables the rapid quantification SUD medication drugs
(buprenorphine, Methadone, Naltrexone) and their metabolites in patients’ urine. The test requires no
special training to operate and qualitative yes/no and quantitative results are visibly
obtained within ten minutes while quantitative results can be measured with mobile-phone-based strip
reader. To circumvent the technical challenge of current lateral flow assay (LFA) strip’s ability to
measure low concentration of SUD medication drugs and their metabolites, we will implement
innovative strip architecture of strip built-in signal amplification by Pt nanoparticle amplified
chemiluminescent(CL) signal readout which enhance the detection sensitivity. To increase the
specificity for drug/metabolite detection, we propose a new lateral flow assay format by using specific
peptide against the immunocomplex of analytes-capture antibody selected from Phage-peptide display
library in the LFA. Furthermore, a Lab-on-Mobile-Device Apps (mReader™) is tailed for strip image
acquisition and quantitative analysis. We will optimize reagent concentrations and LFA parameters
along with statistical validation of dynamic range, specificity, and sensitivity in Phase I project. The
completion of these proof-of-concept studies will demonstrate the ability of this new type LFA to
measure drug concentration in urine samples. In future Phase II, we will: 1) optimize the LFAs
configuration to reduce false negatives and false positives to ensure reliable detection, 2) design and
develop any associated devices (cassette, packaging and labeling), 3) develop smartphone based
quantitative analysis of the LFA test results and data processing Apps recording and wireless
communication of test results, and 4) develop manufacturing processes for pilot scale production of
2000 LFAs and validate the cannabis saliva test with a large cohort of samples (> 250 clinical samples).
At the end of Phase II, the colorimetric LFAs will be ready for transferring to full-scale automated
manufacturing, and the final LFA device will be produced at large scale for clinical validation towards a
defined 510(k) clearance by the FDA.

Public health relevance
Project Narrative Substance Use Disorders (SUD) has become a major public health crisis in the United but many patients often encounter significant barriers to receiving a diagnosis and treatment for SUD due to lack of devices for rapid and low-cost quantitative measurement of drug concentrations and their metabolites for monitoring the compliance and metabolism of SUD medication drugs. If funded, this proposed project will fill current technology void in developing a low-cost, point-of- use, highly sensitive and specific non-instrument test that enables the convenient monitoring SUD therapy.